Isolation and Characterization of Tumor Stem Cells from Melanoma Patients

DESCRIPTION (provided by applicant): The rapid rise of melanoma, in the United States, in the absence of effective therapeutic regimens underscores the urgency and importance of obtaining a deeper knowledge about pathogenesis of this disease. In this project we propose that melanoma is driven by subpopulation of CD271 positive tumor initiating cells. Tumor stem cells (TSCs) in other cancers were shown to be resistant to most conventional chemo and radio therapies, to have the ability to self-renew and efficiently replenish the entire tumor cell population eliminated after traditional medical regimens. Thus to design more successful cancer therapy one must isolate and study the properties of respective TSCs. The primary goal of this proposal is to putatively isolate highly enriched melanoma TSCs from broad spectrum of melanomas and to characterize their molecular profile. We will reach this goal by designing and accomplishing following experimental tasks: 1. Identify and prospectively isolate melanoma TSC by CD271 and additional cell surface markers expression using advanced Fluorescent Activated Cell Sorting and in-vivo tumor transplantation assays. 2. Characterize genetic and/or epigenetic alterations that lie at the root of CD271+ MTSC function by performing global gene expression analysis of MTSCs using microarray and lentiviral reporter technologies; confirm critical role of specific gene candidates in MTSC phenotype 3. Analyze MTSC's advanced tumorigenic properties in the environment that closely reflects natural occurrence of this cancer in humans by characterizing invasive characteristics of MTSCs and a functional role of CD271 in human skin reconstruct mouse model.

Public health relevance
Conventional anti-cancer therapies are developed based on screening method that shrink the size of bulk tumors. While they are effective in reducing the size of the tumor, they may be missing the TSCs or the "roots" of cancer; as a result TSCs can either reconstitute an entire tumor at the primary site or migrate to distal organs. Identification characterization of TSCs in melanomas will open entirely new dimension in treating this disease with targeted therapies that are designed specifically against these cells and in combination with previously known regimens will eliminate all cellular components of the tumor.